Central metabolism of Salmonella in the inflamed gut

PROJECT SUMMARY
Infection with the bacterial pathogen Salmonella enterica serovar Typhimurium (S. Tm) is a common cause of
inflammatory diarrhea. Intriguingly, intestinal inflammation drives an expansion of the S. Tm population in the
gut lumen. The molecular mechanisms that support S. Tm colonization of the intestinal tract remain
incompletely understood. Our central hypothesis is that the inflamed gut constitutes a peculiar nutritional
environment that enables S. Tm to outgrow obligate anaerobic commensal bacteria. We have recently
demonstrated that during the acute phase of the infection, neutrophil-derived electron acceptors facilitate an
oxidative central metabolism in S. Tm. In this application, we hypothesize that S. Tm relies on a branched TCA
cycle for initial gut colonization. In particular, tartaric acid, produced through oxidation of microbiota-liberated
sugars, supports fumarate reduction in the branched TCA cycle. We will test key aspects of our hypothesis by
pursuing the following specific aims: 1.) determine how utilization of D- and L-tartrate contributes to growth of
S. Tm in the lumen of the mammalian large intestine, 2.) determine the origin of tartrate during S. Tm infection,
and 3.) investigate the regulation of tartrate utilization genes in vitro and in vivo. This work will advance our
understanding of how intestinal pathogens, such as S. Tm, adapt their carbon and energy metabolism to
colonize the mammalian intestinal tract. We envision that a better understanding of the mechanisms by which
S. Tm outgrows competing microbes during inflammation will aid the development of new and innovative
approaches for treatment.

Public health relevance
PROJECT NARRATIVE Non-typhoidal Salmonella serotypes are a common cause diarrheal disease in the United States, with a cost of $0.5 to $2.3 billion per year due to lost productivity and the cost of medical care. This application will support studies on how Salmonella colonizes the mammalian intestinal tract and causes disease symptoms. A better understanding of the molecular mechanisms that influence bacterial colonization is expected to aid in the development of new intervention strategies.